Development of a blood-based test for neurodegenerative diseases

STTR Project Summary/Abstract
It is estimated that every fourth to fifth death in the US is caused by a neurodegenerative disease
such as Alzheimer’s, AD related diseases, or Parkinson (CDC Wonder database, 2022;
Alzheimer’s Association, 2022). However, there are very few therapies or even molecular
diagnostic tools to detect these diseases, so the diagnosis of Alzheimer’s and AD-related
neurodegenerative diseases relies primarily on cognitive assessments which typically only occur
with onset of dementia. With no diagnostic test available for the early detection of
neurodegeneration and no ability to differentiate between different neurodegenerative diseases
early on, it is unsurprising that over 43 % of primary care physicians report that they are
uncomfortable diagnosing mild cognitive impairment (MCI) due to Alzheimer’s (Alzheimer’s
Association, 2022). A diagnosis of ‘Alzheimer’s-type dementia’ also often serves as a placeholder
to describe a syndrome of memory loss that can result from various underlying disease causes,
and which may require different therapies. Therefore, we propose to use Covalent Protein
Painting (CPP), a novel platform technology that can detect, identify, and differentiate the
misfolded protein aggregates that characterize AD and related neurodegenerative diseases, to
develop a blood-based diagnostic test for neurodegeneration. Over 80% of primary care
physicians say they would welcome such a test, in particular if such a test could detect AD and
related diseases before patients are symptomatic or only show mild symptoms because it would
help them devise a therapy plan with their patient and allow them to be proactive. Better and
earlier diagnostics would also lead to better therapies, because one of the reasons so many
clinical trials for neurodegenerative drugs have failed is that participants are usually treated too
late, when symptoms are already apparent. Our test would allow earlier enrollment of patients in
clinical trials before too much damage has been done to the brain and would enable better
stratification of patient cohorts, both of which would accelerate and increase success chances of
clinical trials.

Public health relevance
Project Narra+ve STTR An es+mated 6.7 million people live with Alzheimer’s in the US, with Alzheimer and Alzheimer- related diseases being one of the leading causes of death. Yet, a lack of molecular diagnos+c tests to diﬀeren+ate and detect these diseases early on means that diagnosis typically occurs only when demen+a symptoms become apparent and brain damage is already severe, and which has also hindered the development of eﬀec+ve therapies. Here, we propose to use a novel technology called covalent protein pain+ng (CPP) to develop a blood-based diagnos+c test that can for the ﬁrst +me directly iden+fy and quan+fy the characteris+c misfolded protein aggregates thought to exist decades before onset of symptoms and that holds promise to deliver a diﬀeren+al and early diagnosis for several neurodegenera+ve diseases.